Direct to consumer marketing to engage Veterans in evidence-based psychotherapies for PTSD

Evidence-based psychotherapies (EBP) are the most effective treatments for posttraumatic stress
disorder (PTSD; APA, 2017; VA/DoD, 2017) and yet remain significantly underutilized (Hundt et al., 2017;
Kehle-Forbes et al., 2016). Patient level barriers to EBP use including patient knowledge about EBPs, stigma,
and concerns about treatment effectiveness or treatment demands (e.g., Hundt et al., 2015). Interventions that
increase the rate of EBP initiation in Veterans with PTSD can substantially improve symptom burden,
functioning, and quality of life (APA, 2017). Direct to consumer (DTC) marketing strategies, in which a service
or product is advertised directly to the end user rather than a health care provider, are frequently used and
highly effective at driving demand for psychotropic medications (e.g., Avery et al., 2012; Woloshin et al., 2001).
DTC marketing may be particularly effective for EBPs because advertisements can directly target some of the
primary barriers to EBP use.
However, the limited existing studies on DTC marketing for mental health have focused on patient-
reported intentions to engage in treatment, rather than actual therapy-seeking behaviors (e.g., Brecht et al.,
2017; Gallo et al., 2013). Second, no studies have systematically compared different DTC marketing
messages. This is an important omission because not all message types work for all products and for all
consumers (Belch & Belch, 2017; Ogivy, 1985). Third, most prior studies of DTC advertising for psychotherapy
have presented their messaging to the general population, rather than selecting for participants who need
psychotherapy, which limits the applicability of their conclusions to target populations, and no studies have
specifically focused on Veterans or those with PTSD.
Guided by the Theory of Planned Behavior (TPB; Ajzen, 1991) and Veteran and provider stakeholder
feedback, the current study proposes to develop and test different versions of DTC advertising messages
aimed at increasing engagement in EBPs for PTSD. Although VA has invested considerable resources in
advertising campaigns for mental health, PTSD education and outreach materials, no research has examined
which strategies would be most effective at increasing Veteran initiation of psychotherapy. Having this
information would help VA focus its limited financial resources on the most effective DTC advertising strategies
and messages, which has the potential to engage more Veterans in the most effective treatments and reduce
the burden of untreated PTSD (e.g., Zatzick et al., 1997; 2008; Kessler, 2000). This proposal aligns with the
2019 VA priorities emphasizing research on high priority mental health conditions, such as PTSD, and
increasing return on investment in EBP training and increasing efficiency by facilitating uptake of the most
effective treatments for PTSD.
In pilot work, Veterans, family members, providers, and Veterans’ Service Organization members
provided feedback on which DTC advertising strategies would be most compelling to them. Based upon these
early qualitative insights, preliminary work, input from national partners, and our theoretical model, we have
selected advertising strategies that qualified for further testing on a larger scale. These include the testimonial
strategy, the utility strategy, and the compare/contrast strategy. In the course of the proposed study, we will
develop brief advertising videos with iterative feedback from Veteran, family member, and provider
stakeholders and test the effectiveness of these DTC advertisements in a RCT with Veterans who screened
positive for PTSD but are not currently in psychotherapy. Primary outcomes will include Veteran attitudes
about psychotherapy, intention to seek psychotherapy, and initiation of a referral for psychotherapy. The
results of this study will provide invaluable information to help VA target its limited advertising and outreach
budget to the most effective strategies and messages for Veterans.

Public health relevance
Direct to consumer (DTC) marketing strategies, in which a service or product is advertised directly to the end user rather than a health care provider, are frequently used and highly effective at driving demand for psychotropic medications (e.g., Avery et al., 2012; Woloshin et al., 2001). DTC marketing may also be effective at driving Veteran demand for evidence-based psychotherapies (EBPs) for posttraumatic stress disorder (PTSD) because advertisements can directly target some of the primary barriers to EBP use. This proposal aims to develop DTC marketing advertisements for EBPs based upon established strategies from the marketing literature (e.g., testimonials, the utility strategy, and the compare/contrast strategy) and with input from Veteran, family member, and other stakeholders. In a randomized controlled trial, we will test their effectiveness at improving Veterans’ attitudes about psychotherapy, intention to seek psychotherapy, and initiation of a psychotherapy referral, compared to control conditions.